Wearable Vibration Device to Prevent Bone Loss in Postmenopausal Women

Abstract
Approximately 43 million Americans suffer from osteopenia, a highly common skeletal condition defined by
accelerated bone loss. If bone loss is not mitigated, patients become osteoporotic and are at increased risk of
bone fractures, particularly of the hips and spine. Such fractures decrease independent living, shorten life, and
increase morbidity. Clinical guidelines for treating osteopenia include both dietary modifications and high impact
exercise. While diet and exercise can be effective at maintaining bone mineral density (BMD), compliance is low.
The alternative is bisphosphonates, which effectively inhibit bone resorption. However, due to the potential for
serious adverse events with prolonged use, bisphosphonates are only prescribed once bone mass reaches
osteoporotic, or near-osteoporotic levels, when the antifracture benefits of bisphosphonates considerably
outweigh their potential for harm. Recently, devices that deliver mechanical stimulation to the weight-bearing
skeleton have been shown to provide significant benefits for hip and spine BMD. These whole body vibration
(WBV) platforms require the user to stand on a vibrating platform each day to mimic the effects of high-impact
exercise. Despite promising results with WBV platforms, these devices have had limited commercial success as
they are expensive ($1,500-$5,000), cumbersome to use, and inconvenient. To address the need for a safe,
effective, convenient, and cost-effective osteopenia treatment, Bone Health Technologies has developed
OsteoBoost, a wearable, home-use device designed to deliver localized mechanical stimulation to the hips and
spine. With clinical evidence that OsteoBoost provides short- and long-term benefits for combating the effects of
osteopenia, the goal of this Commercialization Readiness Pilot (CRP) is to support the commercialization of a
cost-competitive OsteoBoost device. First, to determine if bone turnover markers (BTMs) can be used to provide
patients with an earlier indication of therapeutic effectiveness than a 6-month DXA scan, we will evaluate the
effects of OsteoBoost treatment on key BTMs in a 3-month, sham-controlled clinical study (Aim 1). Second, we
will update the OsteoBoost design with a reduced cost of goods sold (COGS) to enable profitable commercial
launch (Aim 2). Third, we will conduct a comprehensive set of verification and validation testing on our COGS-
reduced device and submit a De Novo application to the FDA for OsteoBoost (Aim 3). The successful completion
of these aims will allow us to commercialize this refined system within 2.5 years of the funding of this proposal,
thus providing a much-needed comprehensive treatment option for the millions of Americans with osteopenia.

Public health relevance
Narrative Osteopenia, which affects approximately 43M Americans, is a common skeletal condition that is defined by an accelerated loss of bone mass that can lead to osteoporosis if not treated. Bone Health Technologies has developed OsteoBoost, a wearable vibration device that is designed to provide safe, effective, and convenient mechanical stimulation to the hips and spine to mitigate bone loss associated with osteopenia. In this Commercialization Readiness Pilot (CRP) project, we propose to expand upon our Phase II work to support regulatory approval and commercialization of a cost-competitive OsteoBoost device.